Pan Omics and Data Science Core

ABSTRACT (Pan Omics and Data Science Core)
The use of multi-omics techniques, including single-cell omics, in environmental health sciences (EHS)
research continues to grow rapidly, and the use of advanced machine learning and statistical learning
techniques to make translational predictions with these data is becoming ever more essential. As such,
staying on the cutting edge with these tasks can be overwhelming. The objective of the Pan Omics and Data
Science (PODS) Core is to provide comprehensive and innovative support to investigators in the Michigan
Center on Lifestage Environmental Exposures and Disease (M-LEEaD) for the study design, sample
preparation, analysis, interpretation, and integration of a broad range of omics-based studies, and to educate
them on available opportunities. The PODS Core streamlines the entire process of an omics study, allowing M-
LEEaD investigators to dedicate more of their own resources to answering difficult environmental health
science questions. Lifestage-specific exposures may have detrimental effects on human health via any of
several mechanisms, including epigenetic, genetic, transcriptomic, proteomic, metagenomic, metabolomic, and
adductomic. Thus, in the new funding period the PODS Core aims to broaden its reach both in terms of the
omics technologies supported, and the statistical and data science methods used. We will achieve this through
building a close-knit community of UM experts in these areas and interest/experience in EHS. The PODS Core
objective will be accomplished through four specific aims. First, we will provide M-LEEaD investigators
expertise in the study design and implementation of a broad range of molecular studies, including technology
platform choice, sample collection and preparation, and engagement with key UM resources. Second, we will
provide bioinformatics analysis and data science services for a broad range of omics approaches and
integrative analyses. Third, the PODS Core will support the community through development of novel
bioinformatics methods and tools and protocols for novel technologies staying apace with technological
advancements. Finally, the PODS Core educates M-LEEaD Center faculty, staff, and students on omics
assays and data science relevant to EHS research, and promotes partnerships between environmental
scientists and data scientists. M-LEEaD investigators benefit from several free services and collaborative
events offered by PODS, which enables and strengthens Fundamental Questions and also Application and
Synthesis in the NIEHS Translational Research Framework.